VTA-NAc GABAergic communication underlying stress-induced reward deficits

Millions of Americans suffer from deficits in reward-seeking, in the context of psychiatric disorders, such as major
depressive disorder, schizophrenia, and substance use disorders. Stress can both exacerbate these disorders
and directly cause reward-seeking deficits. Mice subjected to chronic stress also develop reward-seeking
deficits. However, it remains unclear how stress disrupts reward-seeking. Reward-seeking is a complex process
that includes anticipatory motivation to obtain rewards, an assessment of the hedonic value of rewards, and
learning to associate reward-predicting cues with rewarding outcomes. Communication between the ventral
tegmental area (VTA) and the nucleus accumbens (NAc) plays a central role in these processes. Dopamine (DA)
released from the VTA to the NAc supports components of reward-seeking, including anticipation and learning.
Yet efforts to show that VTA-NAc DA deficits underlie stress-induced reward-seeking deficits have yielded mixed
results. Recently, researchers have identified that inhibitory VTA GABA neurons are also key for setting
expectations that both guide reward anticipation and associative learning. We have found that during acute
stress, these VTA GABA neurons induce rhythmic NAc activity and that this activity predicts subsequent transient
reductions in reward-seeking. Moreover, rhythmically stimulating NAc projecting VTA GABA neurons suffices to
recapitulate both stress-induced NAc rhythmic activity and subsequent reward-seeking deficits. These data raise
the possibility that chronic stress causes reward-seeking deficits via VTA-NAc GABA activity. Since VTA GABA
neurons have known roles in anticipation and learning, these data also suggest that chronic stress might disrupt
encoding of specific aspects of reward-seeking. This proposal tests these ideas and directly links chronic stress-
induced VTA-NAc GABAergic activity to subsequent deficits in the encoding of reward-seeking. Specific Aim 1
will test whether two chronic stress disrupts specific aspects of reward-seeking using tasks that assess
associative learning, anticipatory motivation and hedonic valuation and consider mice along the susceptible-
resilient spectrum. Specific Aim 2 will use optogenetics and chronic in vivo multi-site electrophysiology in awake,
behaving mice to test whether VTA-NAc GABAergic activity causes chronic stress-induced reward-seeking
deficits by recording the in vivo firing activity of VTA-NAc GABA projections during chronic stress and subsequent
reward-seeking. We will also determine whether chronic optogenetic stimulation of this pathways suffices to
induce persistent reward-seeking deficits. Finally, Specific Aim 3 will use pathway-specific chemogenetic
blockade to test whether blocking VTA-NAc GABAergic activity can prevent chronic stress-induced reward-
seeking deficits. We will also use Cal-Light (calcium and light-activated gene expression) to express an inhibitory
opsin in stress-activated VTA neurons. This technique will allow us to test whether inhibiting stress-activated
neurons during reward-seeking can reverse the effects of chronic stress. With this approach, we will develop
pathway and cell-type specific understanding of how chronic impairs reward-seeking with the goal of finding
novel treatments for reward-seeking deficits.

Public health relevance
Project Narrative Millions of Americans suffer from deficits in reward-seeking in the context of psychiatric disorders, such as major depressive disorder, schizophrenia, and substance use disorders. Stress can both exacerbate these disorders and directly cause reward-seeking deficits. In this project, we will use recent discoveries about inhibitory cells within a key reward circuit in the brain (ventral tegmental area to nucleus accumbens) to uncover the mechanism by which stress causes reward-seeking deficits and to discover ways to prevent and reverse these negative effects of stress.